Addressing Misinformation to Promote Equity in Prostate Cancer Care - Revision - 1

PROJECT SUMMARY/ABSTRACT
This application is in response to the Notice of Special Interest (NOSI) identified as NOT-CA-23-041. Prostate
cancer information shared through popular social networks such as YouTube, Instagram, and TikTok is widely
viewed but misinformation is common. The impact of social networks on patient-physician communications about
prostate cancer is unknown. We will address this research gap using three main approaches: (1) compare the
quality of information, understandability, and actionability between social media posts about prostate cancer in
English and Spanish by healthcare providers versus other publisher types; (2) explore the use of social media
platforms for direct patient-physician communications about prostate cancer; and (3) explore the perspectives of
healthcare providers serving diverse communities on the positive and/or negative impacts of social media for
patient-physician communications. Results of this study will be used to create a tip sheet for health care providers
on best practices for patient-facing social media communication, and will be moved forward in later years of the
project to discuss with Black and Hispanic patients the impact of social media for their communications with
healthcare providers and clinical decision-making. Our multi-disciplinary team is well-suited to conduct this study
with expertise in prostate cancer, biostatistics, qualitative research, health literacy, and social media. The
expected outcomes of this study will advance the field by studying ways that social media can be leveraged to
improve patient-physician communications.

Public health relevance
Project Narrative Social networks are widely used by patients and healthcare providers related to prostate cancer; however, little is known about the use and impact of social media for patient-physician communication. We will study the quality and understandability of social media postings made by healthcare providers, their use of social media for direct communication with patients, and their perspectives on the impact of social media for patient- physician communications. Our proposed work seeks to advance the field through a better understanding of the effects of social media as a form of digital health on patient-physician communications to inform the development of more effective digital communications about cancer from healthcare providers.